Amygdala Mediated Mechanisms Regulating Visceral Pain

Chronic visceral pain is a significant problem in the US and current treatments are largely ineffective. Why
visceral pain is so poorly managed is unknown, but we have demonstrated that adult male and female rats
develop visceral hypersensitivity to colonic distension after chronic psychological stress, with a significantly
exaggerated response in females. Moreover, we found that female rats exposed to unpredictable early life
stress (ELS) exhibit visceral hypersensitivity as adults, whereas males have no evidence of increased colonic
sensitivity. Together, this evidence points to a sexually dimorphic female vulnerability to stress-induced colonic
hypersensitivity. Our preliminary data also indicates that epigenetic modifications contribute to stress-induced
visceral pain through alterations in glucocorticoid receptor (GR) and corticotropin-releasing hormone (CRH)
expression in the central nucleus of the amygdala (CeA). However, three important questions still remain: 1)
Do sexually dimorphic differences in the expression of GR and CRH within the CeA explain why females are
more susceptible to chronic stress-induced visceral pain? 2) Do specific epigenetic mechanisms in the CeA
explain why exposure to unpredictable ELS confers visceral pain vulnerability in female rats while male rats are
resilient? 3) Is the CeA the fulcrum for the development of stress-induced visceral pain. To provide answers
Aim 1 will utilize state-of-the-art approaches to focus on epigenetic dysregulation in the CeA that mediate the
persistent sexually dimorphic effects of adult stress on hypersensitivity. Aim 2 we will take advantage of pivotal
preliminary data to test the hypothesis that there are sexually dimorphic epigenetic mechanisms within the CeA
conferring visceral pain vulnerability in adult females following unpredictable ELS. Aim 3 will determine whether
stress-induced changes in visceral nociceptive processing are specific to the amygdala. Taken together we are
proposing a novel approach by using state-of-the-art epigenetic techniques combined with behavioral out-
comes to identify mechanisms to enhance our basic understanding of chronic visceral pain. Specific Aim 1 will
show that heightened visceral pain following chronic adult stress is modulated through epigenetic mechanisms
within the CeA. Specific Aim 2 will show that as adults, female rats exposed in unpredictable ELS have an
epigenetic signature in the CeA that differs from male rats and aim 3 will investigate the amygdala specificity of
our findings. This application will build upon our novel preliminary findings and take full advantage of cutting-
edge approaches to delineate central molecular mechanisms leading to stress-induced chronic visceral pain.
RELEVANCE TO HUMAN HEALTH: This NIH R01 grant will substantially advance our knowledge of the
neural and molecular level events responsible for chronic pain, and with our previous data provide a unifying
hypothesis for how stress leads to chronic pain. Scientifically, the results will identify novel sexually dimorphic
mechanisms and circuitry involved in female vulnerability to develop chronic stress-induced pain, leading to
new targets for therapies to treat chronic pain, which is a significant unmet healthcare burden.

Public health relevance
Project Narrative To improve the lives and the treatment options of patients with Irritable Bowel Syndrome (IBS), this NIH grant focuses on understanding the basic mechanisms that underlie stress-induced chronic visceral pain. It is our overarching hypothesis that neuroplastic changes within amygdala lead to stress-induced chronic visceral pain, which if correct, will result in an enhanced understanding of the mechanisms by which stress alters behavior to worsen and prolong pain disorders. Importantly our findings may identify novel approaches and targets for new therapies directed at the brain to improve the treatment or even reduce the risk for the development of chronic visceral pain.